Duke University Maternal-Fetal Medicine Units (MFMU) Network Clinical Center

ABSTRACT – Duke University Maternal-Fetal Medicine Units (MFMU) Network Clinical Center
The Duke Clinical Center will be a new center that participates in the full scope of the Network, enrolling a diverse
population of patients at Duke as well as a Wake Forest University (WFU) satellite site. Duke has a long history
of participation in the MFMU Network, first as a clinical center, and most recently as a satellite center. In addition
to conducting trials in the MFMU Network, the Duke Perinatal Research Center (DPRC) has vast experience in
enrolling for randomized trials and cohort studies with NIAID and CDC Networks. The Duke Clinical Center will
bring special strength in developing new research protocols, particularly in the areas of infectious diseases in
pregnancy and health disparities in preterm birth. The diverse research population available in the center’s
catchment area includes an enriched representation of Black and Latinx from multiple Duke locations, as well as
WFU. Moreover, the team has a strong track record in clinical trials collaborations, recruitment, retention, and
follow up that will contribute to the Network’s goals of enhancing rigor and reproducibility, data sharing, and
inclusion of diverse patient groups and workforce. The Center has large scale outpatient facilities as well with
an established infrastructure for enrolling patients at both high risk clinics as well as in collaboration with
generalist obstetrics partners in low risk clinics. The Duke Clinical Center, supported by Clinical and Translational
Science Awards (CTSAs) at both Duke and WFU, will promote an environment of equity and inclusion, fostering
a respectful climate for all investigators, patients, and participants. The team has a strong history of collaboration
with specialists in pediatrics, pharmacology and lactation and will leverage those collaborations to bring forward
innovative, high quality science to the MFMU Network. The proposed specific aims for the Duke Clinical Center
are Aim 1. Oversee and manage operations of the Duke Clinical Center – provide the infrastructure,
oversight, expertise, and resources to conduct Duke Clinical Center studies, including contributions from the
WFU satellite site (and any future MFMU Network-designated sites); administrative, scientific, fiscal, and data
management; communication, collaboration, and coordination processes within and between sites. Aim 2.
Maximize recruitment and retention of study participants, as well as investigators and staff, from diverse
populations – use innovative strategies, such as community-based partnerships, bilingual research staff, and
conduct of community-engaged research and qualitative methods for enrolling subjects in Network studies. Aim
3. Design and implement high-impact research protocols in collaboration with the Data Coordinating
Center and other Network sites – contribute innovative research specifically in the areas of infectious diseases,
perinatal pharmacology, disparities in preterm birth, and perinatal epidemiology; ensure rigorous collection of
reproducible, high-quality data; and leverage institutional resources to maintain robust collaboration between the
investigators and clinical research teams

Public health relevance
PROJECT NARRATIVE Maternal and infant morbidity and mortality are public health crises, particularly among Black pregnant individuals in the United States. Clinical trials and community-engaged research that ensure diverse participant enrollment are needed to address health disparities and appropriately treat pregnant individuals. The Duke Clinical Center of the Maternal Fetal Medicine Units Network will lead and participate in clinical trials and research vital to decreasing the unacceptable rates of adverse outcomes and health disparities.